ADMINISTRATIVE CORE

As the lead investigator, Patricia K. Donahoe, MD, will serve as the Director of this Program Project to oversee and coordinate, with her Administrative Core, all aspects of this extensive endeavor. Dr. Donahoe will design and plan Project UI, coordinate all research for Projects I, II, and III, with their respective Principal Investigators and with the two other Core Directors. She will negotiate and coordinate platform availability, working closely with each investigator at each site to prioritize and budget genes selected for validation, resequencing, and the choice of animal models or IPS study for functional assessment. The Administrative Core of this Program Project will serve as "traffic control" to quickly and efficiently communicate with all Program staff and assign tasks to the appropriate sites as deemed by the Director and Principal Investigators, and to monitor and assist laboratory staff in their completion. Weekly communications between sites will be done by direct contact or by videoconferencing using a PolyCom VSX70005 system.